Core A: Administrative Core

ABSTRACT
The large number of sites (14) and the international nature of the READD-ADSP proposal make the logistical,
regulatory and financial aspects particularly complex. Core A, the administrative core, provides the necessary
oversight, coordination, and administrative infrastructure for this proposal. Core A will oversee the regulatory
and financial aspects of our international collaboration and assure broad data sharing. The proper sharing
of data and samples being collected necessitates the execution of a number of institutional agreements and
assurance that the proper IRBs are in place. Core A will ensure that all documents have been signed and IRB
approval has been obtained prior to the transfer of samples. An experienced Director of Finance will oversee all
financial aspects, with close interaction and collaboration with the individual Core, Project and Site PIs at the
different READD-ADSP institutions. Core A will coordinate and integrate all READD-ADSP components and
activities. In a study this large, frequent communication is imperative. Semi-monthly video conferences of the
MPIs and investigators will be organized and managed by Core A. Core A will coordinate and organize
internal executive and external scientific advisory committee meetings. An internal executive committee of
all the MPIs will meet every other month to review progress and address any outstanding issues. An external
scientific advisory committee comprised of individuals with relevant expertise will meet four times a year (one in-
person) to provide feedback. Core A will support these meetings and ensure that any recommendations are
implemented. Lastly, Core A will facilitate the interaction with scientific communities relevant to READD-
ADSP goals as well as the lay public. A resource is only valuable if people are aware of it. Core A will assist
investigators with publicizing their work through national/international meetings, publications, and press releases
and through the development of a website. The website will also contain information geared to the lay audience,
including highlights of research funding and participation opportunities. Core A will also interface with NIA to
keep them apprised of findings and to implement any changes that NIA requests.